Center for Clinical and Translational Sciences

PROJECT SUMMARY/ ABSTRACT
Since its inception in 2006, our CCTS has assembled a well-integrated, and high-impact network in Texas
including 6 academic institutions: The University of Texas Health Science Center at Houston (UTH-H), the
University of Texas M.D. Anderson Cancer Center (MDACC), Rice University, University of Texas at Tyler (UT-
Tyler), University of Texas Rio Grande Valley (UT-RGV), and two UTH-H affiliated hospital systems (Memorial
Hermann and Lyndon B. Johnson County Hospital). We have actively supported and integrated our partners into
NCATS national initiatives, including recent recruitment of a large number of diverse patients for COVID-19 trials
and studies. Over the past 17 years, our CCTS has supported investigators at 30 institutions from over 97
biomedical fields who disseminate scientific and healthcare initiatives that impact diverse populations. By
expanding our network to include Texas Tech University Health Sciences Center El Paso (TT-EP), our catchment
now encompasses ~23,000 sq. miles and over 16 million residents (4% of the U.S. population) showing some
of the greatest diversity in the country. Each partner institution brings communities with unique geographic,
demographic, cultural and socio-economic characteristics and challenges. In the next cycle, we will thoroughly
integrate translational science into our entire program and expedite the output of scientific
observations
policies
discoveries, clinical
and community experiences into effective treatments, clinical interventions and public health
that improve the health of people within our diverse state and beyond.Our shared leadership model and
partnerships across the disparate regions of Texas will enable us to carry out our 6 strategic goals: (1) Enhance
our robust organizational structure of Cores to improve and expand the impact of CCTS programs on
translational science (Element B); (2) Promote partnerships and collaborations of stakeholders that extend
benefits of translational science to underserved populations (Element B & Module C2); (3) Enhance integration
of D&I sciences across our CTSA (Module C2); (4) Innovate scientific and operational functions of CRUs to
expand the effectiveness and accessibility of CTS in broadly heterogeneous populations (Module D1); (5) Foster
education and career training in translational science by establishing methods that inspire our growing workforce
of clinical research professionals (Modules C1 & D2); (6) Create and disseminate innovative Health Informatics
(HI) solutions to become a national resource for the response to urgent public health needs of underserved
populations (Module D3). To accomplish these strategic goals, we will pursue our 3C's and 5I's motto:
Community, Collaboration & Careers (3C's) and Impact, Inclusion, Implementation, Innovation, & Informatics
(5I's). Our leadership and organizational model, resources, partnerships, and research infrastructure have been
strategically planned so
diagnosis,
goal
that more people get the benefits of translational science, from access to accurate
efficacious treatment to cost-effective disease prevention strategies. This is our mission and our major
which reflectsNCATS's vision: a world with “more treatments for ALL people more quickly”.

Public health relevance
: The CCTS is uniquely positioned to advance translational science through strategic expansion and multi-disciplinary collaboration to maximize resources and diversify capabilities that accelerate the “translation” of scientific discoveries into patient-care. Our Hub will focus on the large population we serve across Texas to address specific needs, and design feasible approaches to make them applicable locally, regionally and nationally. Through Research, Training & Team Science, Community Engagement and Diversity, the CCTS will contribute to NCATS’ national efforts towards innovative solutions resulting in “better health for all”.